Emergent Behavior in a Dish: Discovery of Bi-directional Spiraling as a Population Phenomenon in C. elegans Enables In-Depth Dissection of Mechanisms Underlying Group Behaviors

Project Summary/Abstract
Emergent behaviors arise when individuals follow rules about how to interact with one another and their
environment to produce a group entity with new properties or abilities1,2. Common examples include a school
of fish, a flock of birds, and a colony of ants. In an emergent behavior, individuals often simultaneously
communicate with multiple other individuals while processing sensory cues from the environment2,3. All this
information is integrated to produce a behavioral response that is remarkably cohesive across the group.
Though complex information integration is a hallmark of how humans process the world, the mechanisms
underlying communication in groups have been difficult to probe experimentally. I have discovered the first
example of emergent group behavior in C. elegans in which individuals coordinate motion without being in
physical contact: in response to a simple environmental cue, a population of several hundred individuals will
synchronously perform an inward bidirectional spiral that eventually concentrates the initially dispersed
population at a central point. The behavior occurs when a lid is placed on an open dish containing a sufficient
density of worms in the absence of food and is dependent on intact sensory systems. Furthermore, I have
demonstrated that a cue from a high density population can be sensed across a shared airspace to induce
spiral-like behavior in individual worms that would not otherwise show spiral motion. I therefore propose that C.
elegans uses a volatile cue to gauge population density, and spiraling behavior is triggered by concentration of
this cue when the dish is closed. However, I also demonstrate that accumulation of a cue is not sufficient to
induce spiraling if inter-worm distance is too great indicating that local cues between neighboring worms are
also involved in coordinating spiraling. In Aim 1, I will elucidate the cues that individuals produce and perceive
to facilitate emergent spiraling in C. elegans including both long-range density cues and short-range cues from
nearby individuals. In Aim 2, I will take advantage of the tractability of C. elegans to ask how brain activity
produces emergent spiraling behavior. C. elegans are transparent, and the brain activity of individuals can be
directly visualized by following calcium transients in freely moving worms4. I will explore the hypothesis that
neural networks reduce the noise of inputs to produce maximally coherent behavior across individuals in the
collective. Together these findings will illuminate principles underlying emergent behavior at unprecedented
resolution which may allow us to identify similar processes occurring in other systems or design artificial
systems which exhibit spiral behavior.

Public health relevance
Project Narrative Many individuals following a set of rules about how to interact with one another and the environment can give rise to a group entity with new properties in a phenomenon known as emergence. To produce emergent behavior, animals must communicate with multiple other individuals while simultaneously processing sensory cues from the environment and then integrate this information into a cohesive behavioral output. While emergent behaviors have traditionally been challenging to study, my discovery of bidirectional spiraling as a novel emergent behavior in the highly tractable nematode C. elegans presents an opportunity to elucidate the communication mechanisms and neural dynamics underlying a collective behavior with implications for disorders marked by failure to integrate sensory and social cues.